Dissecting host and microbial contributions to gut microbiome homeostasis

Project Summary
The goal of this project is to understand how interactions between host physiology, microbial metabolism and
gut ecology interact to determine gut microbiome dynamics and gut homeostasis in the context of dietary
variation. Gut microbes play key roles in the digestion of food, acquisition of nutrients, and defense against
pathogens. The gut microbiota of omnivores must be able to maintain homeostasis and continue to carry out
these functions in the face of a diverse and variable host diet. We propose to develop omnivorous cockroaches
as a new model system for identifying and characterizing host and microbial responses to dietary shifts.
Cockroaches are unusual among insects in that they host a highly diverse hindgut microbiota that is
taxonomically and functionally analogous to the colonic microflora of humans. This property, along with their
tractability to experimental and dietary manipulation, makes them ideal as a low-cost insect model for the study
of gut microbiome homeostasis and dysbiosis. We have discovered that the gut microbiota of cockroaches is
highly stable, with low individual-to-individual variability and exhibiting minimal variation in taxonomic
profile in the face of major alterations in dietary composition. We hypothesize that this stability may be due to
1) host-microbe metabolic cross-feeding 2) stabilizing interactions and metabolic co-dependencies among gut
microbes or 3) a high degree of metabolic flexibility in cockroach gut microbes. These hypotheses are not
mutually exclusive, and multiple mechanisms may be acting in concert. We will test these hypotheses using a
combination of molecular and experimental approaches. We will utilize metagenomic and metatranscriptomic
techniques to study cockroach gut transcriptional and metabolic networks and how they change in response to
dietary variation. We will also develop a culture library of abundant and ecologically important cockroach gut
microbes to study gut microbial metabolic capabilities, genome variation, and nutritional dependencies. Follow-
up studies will utilize gnotobiotic insects to study host-microbe and microbe-microbe interactions in simplified
model communities, and will incorporate behavioral interventions to evaluate the role of environmental
transmission and social behavior in shaping gut microbiome dynamics. Together, these efforts will extend our
understanding of host and microbial contributions to gut homeostasis, and will enable the development of new
and improved strategies to alter gut microbiome structure and function in humans.

Public health relevance
Project Narrative Gut microbes play major roles in shaping human health, and alterations in gut microbiome function have been associated with numerous diseases, including antibiotic-associated diarrhea, malnutrition, obesity, diabetes, metabolic disease, inflammatory bowel disease and gastrointestinal cancer. However, efforts to develop strategies for altering the gut microbiome in humans through dietary intervention, prebiotic or probiotic treatment, and microbial transplantation have been hindered by our poor understanding of host, environmental, and microbial drivers of gut microbiome structure and function. Here, we propose to use omnivorous cockroaches as an experimental system to study the role of host and microbial physiology and behavior in shaping how the gut microbiome responds to changes in host diet, with the aim of developing new strategies for inducing favorable changes in gut microbiome structure and function.